Investigating the role of structural variation in hominin evolution.

PROJECT SUMMARY
Along with differences in the environment, genetic variation is the ultimate source of phenotypic diversity within
and between species. Due to the limitations of traditional short-read sequencing technologies, most research in
human genetics and evolution has focused on single-nucleotide variants (SNVs) and short insertions and
deletions. The recent development of long-read sequencing technologies has begun to reveal the prevalence
and phenotypic impacts of larger insertions, deletions, and rearrangements, collectively termed structural
variants (SVs). However, long-read sequencing methods remain impractical for large-scale application due to
their high cost and low throughput. Consequently, the role of SVs in human evolution is still poorly understood.
These challenges motivate the development of innovative computational approaches that combine the
accuracy of SV discovery using long reads with the scale and global diversity of short-read sequencing
datasets. To advance knowledge of how SVs impact fitness and genome function in humans, this proposed
research project will:
1. Identify locally adaptive SVs by leveraging graph-based methods for SV genotyping. This approach
enables accurate genotyping of SVs discovered with long reads in short-read datasets from diverse
human populations. The population-wide genotypes generated with this method will allow for the
discovery of signatures of historical positive selection on SVs.
2. Discover SVs that are shared among or exclusive to the modern human, Neanderthal, and
Denisovan lineages using both graph genotyping and alignment-free methods. Placing SVs in their
comparative evolutionary contexts will reveal divergent variants that may underlie important functional
differences that distinguished these hominin groups.
3. Quantify the functional genomic impacts of SVs by combining long-read and short-read RNA
sequencing of diverse human individuals. This data will reveal insights into how SVs may mediate
phenotypic differences through effects on gene expression and splicing.
This research will be conducted in a strong genetics and genomics training environment, and will combine the
evolution, computational genomics, and long-read sequencing expertise and resources of my sponsor, co-
sponsor, and collaborator. My project will provide me with scientific training in evolutionary modeling,
development of software tools, and functional genomic data analysis. Meanwhile, the institutional environment
will also facilitate my training in the communication, teaching, mentorship, and leadership skills that are
essential for becoming a leading researcher in human genetics.

Public health relevance
PROJECT NARRATIVE The genetic variants that distinguish us from other human beings range in size from one to thousands of base pairs, but the limitations of standard sequencing technologies restrict most research to only the smallest variants. My project will leverage novel computational approaches and sequencing methods to study the evolutionary impacts of large insertion, deletion, and rearrangement mutations in humans, which have been historically overlooked in genetic studies. The results of this work will reveal insights into how these understudied variants affect human genome function and fitness, informing future research into the evolutionary and molecular causes of human diseases.